Research on normal and abnormal mechanisms of vision

University of Pennsylvania Vision Training Program, Project Summary
We propose to continue a broad, interdisciplinary Vision Training Program (VTP) now in its 45th year. The
program includes 25 trainers in 8 departments across 4 schools with expansive expertise in many areas of vision
science and ophthalmology including: the eye (optics, cornea); phototransduction (biophysics, molecular
biology); retina (circuitry, neurochemistry, developmental genetics, disease, gene therapy, optogenetics); central
pathways (physiology, computation, neuroimaging); and higher processes (psychophysics, cognitive
neuroscience, computation). The purpose the VTP is to promote intellectual development of outstanding trainees
interested in the visual sciences so that they may ultimately become leaders in their chosen disciplines. Our
most recent renewal of the VTP supported predoctoral trainees only; we propose to expand our training group
to include postdoctoral fellows in the upcoming cycle. Predoctoral admissions to PENN are highly competitive
with top tier students admitted under a “graduate group” which oversees the broad coursework completed over
the first two years of study, laboratory rotations, and placement in research labs. Postdoctoral fellows are
admitted directly to laboratories by the individual Principle Investigators. The VTP typically accepts predoctorate
students from the Neuroscience, Psychology, Cell and Molecular Biology, Pharmacology, or Bioengineering
graduate groups who are in their third year of training and have completed their coursework, passed a
candidacy/qualifying exam, and joined a research lab devoted to Vision Science or Ophthalmology. Postdocs
will be accepted to the VTP in their initial appointment years. Because trainees come from these different
academic backgrounds, the VTP is critical for providing a unified program encompassing a broad array of topics
yet providing an in depth education on state-of-the-art approaches for studying Ophthalmology and Vision
Science. In addition to the rigorous and impactful research projects expected of our trainees, the VTP includes
a Vision Seminar Series (comprised of visiting external faculty and scientists), the PENN Vision club (comprised
of speakers from PENN), and the Vision Retreat (including student speakers and a visiting Scholar-in-
Residence). This cycle we also are adding a series of workshops on “Research Methods in Vision Science from
Cornea to Cortex” which will include opportunities for trainees to shadow ophthalmology clinics, gain experience
with retinal imaging in humans and animal models, observe neurophysiology, neural recording and neuroimaging
experiments, and learn statistical approaches for ophthalmology and vision science including considerations for
inter-eye correlation. Postdoctoral trainees will also join a “Grant Proposal Success” group which serves as a
mock study section. In the past 10 years, the Vision Training Program has trained or is training 18 PhD/MD or
PhDs with most continuing their careers at prominent research institutions. The impact of our training program
has been widespread, adding significantly to our understanding of vision in health and disease.

Public health relevance
Project Narrative The Vision Training Program (VTP) at the University of Pennsylvania supports the intellectual development of outstanding predoctoral and postdoctoral trainees interested in Vision Science and Ophthalmology. The VTP provides a unifying program across a broad array of vision science methods and expertise which includes the Vision Science Seminar series, the PENN Vision club, a Vision Retreat, and a series of hands-on workshops covering Research Methods in Vision Science from Cornea to Cortex. The program continues to be highly successful, as demonstrated by the high number of impactful publications produced by our trainees along with our trainees' success in continuing in research oriented careers after completion of their training at PENN.